Propriopsinal neuron function in normal and post-SCI locomotion

Abstract: Despite the more than 100 years since the recognition of intrinsic spinal locomotor circuits, many of
the functional details of those circuits and their contributions to recovery following spinal cord injury (SCI)
remain to be determined. Recent development of powerful molecular tools enables functional dissection of
neural circuitry via reversibly silencing neurotransmission and trans-synaptic labeling. We will combine these
tools with sophisticated gait and kinematic analyses, that includes the full repertoire of speed dependent gaits,
to provide the functional and anatomical information necessary for building and refining an advanced neuro-
biomechanical computer model of the rat spinal cord, body and limbs. We will focus on two classes of spinal
cord interneurons, the long ascending (LAPNs) and descending (LDPNs) propriospinal neurons, that
interconnect the forelimb and hindlimb circuits and central pattern generators in the two enlargements, and
investigate their role in the intact spinal cord and after SCI using both hemisection and contusion models. Our
preliminary data show that these LAPNs/LDPNs are essential components involved in speed-dependent gait
expression. Silencing these neurons partially decouples the right and left limbs at each girdle. Surprisingly,
silencing these neurons after an incomplete contusion injury results in better overground locomotion, a result
that is hard to reconcile based on current knowledge and observations in uninjured animals. Using viral-based
trans-synaptic labeling we will determine the sensory, descending and propriospinal inputs onto both LAPNs
and LDPNs. We will utilize both existing and new physiological and biomechanical data (Aim 1) as well as new
anatomical data (Aim 2) to build and refine our computational model (Aim 3). Then, in vivo experiments and
computer modeling will be performed in parallel (Aim 4) to determine the roles that ipsilateral and commissural
LAPNs and LDPNs play in locomotor behavior, including the full range of locomotor gaits, and in recovered
function after hemisection and incomplete contusion injuries. We suggest that a deeper understanding of long
propriospinal neurons represents an important step towards the development of new therapeutic tools for
recovery after SCI.

Public health relevance
Project Narrative This multi-PI project focuses on the role of the long ascending and descending propriospinal neurons (LAPNs, LDPNs) in the control of locomotion and recovery after a spinal cord injury. We will use a combination of viral based synaptic silencing, retrograde and trans-synaptic tracing and comprehensive gait and kinematic analysis to aid the development of a neuro-biomechanical computer model and to generate important new knowledge of spinal locomotor circuitry.